Bioinformatics Core

Abstract
The Bioinformatics Core (CORE B) will interface with each projects, cores, and UTSW consortium to provide (i)
centralized bioinformatics and biostatistical support; (ii) centralized database; (iii) integrative data analysis across
different platforms; and (iv) analytical and methodical reports for preparation of manuscripts. Core B Leader, Dr.
Wang, and Co-Leader, Dr. Baladandayuthapani, have been working closely and synergistically for several
years with core and projects leaders and co-leaders, and are capable of supporting study designs, data analysis,
and management of data resources of the entire PDTC program. Core B will use robust IT structure and an
extensive computing environment that includes Windows, Unix/Linux, Mac OS X, and two quad-processor Sun
SPARC SMP systems. In addition, Core B will rely on two primary institutional computing resources, an HPC
cluster of 336 compute nodes (each node with 32GB RAM; 1.3 GB RAM per core) with dual, 12-core Opteron
processors (8,064 CPUs total), and an Itanium-2 SMP compute server with 32CPUs and 128GB RAM. The core
Leader and Co-Leader have built various pipelines for sequencing data and protein expression data processing
and analysis, which will be applied to analyze data. Standard design principles and statistical algorithms will be
used and new methods will be developed as needed. These include: a) Parametric and nonparametric methods
for estimation and hypothesis testing; b) Linear models and generalized additive models to find the best models
that fit complex data structures; c) Kaplan-Meier method to estimate the distributions of time-to-event outcomes;
d) Log-rank test to compare the distributions among different PDX groups; and e) Proportional hazards models
to test for PDXs treatment with single drugs and combinations. Drs. Wang and Baladandayuthapani will work
closely with UTPDTC investigators to facilitate hypothesis testing across projects by integrating datasets from
multiple laboratories using various algorithms, including principal components, partial least squares, and
Bayesian network-based models. Data analyses will be performed using R and Bioconductor packages. The
Core will document all the analyses and produce HTML or PDF reports (using R packages: Sweave, knitR, and
R markdown).